VRSingTogether: Digital therapeutic virtual reality tool to mitigate the effects of Alzheimer's Disease (AD) and Alzheimer's-Disease-Related Dementias (ADRD)

Project Summary
One in three seniors die with Alzheimer’s Disease (AD) or Alzheimer’s Disease related dementias (ADRD). More
than six million Americans are living with AD and by 2050 this number is projected to rise to nearly 13 million.
The economic costs of AD are significant, with 355 billion in national costs for caring for people with AD and
ADRD. Disconcertingly, there is also an estimated 256 billion in care provided by family members and other
unpaid caregivers. These statistics illustrate the necessity for scalable strategies and interventions to delay the
onset of and halt the progression of, AD and ADRD. Indeed, a 2020 report by the Lancet indicated that 40% of
dementia cases could be prevented by modifying lifestyle factors; with a recommendation for individuals to
maintain cognitive, physical, and social activity through midlife and beyond. Crucially, interventions should be
initiated as early in the disease process as possible—in those with normal cognition or only mild cognitive
impairment (MCI)—as the effects of lifestyle factors on dementia onset are cumulative. In fact, the MCI
designation itself was developed to signal that a patient is at higher risk for AD/ADRD, prompting enhanced care.
Importantly, existing solutions leveraging technology lack the ability to combine physical, cognitive, and social
modalities together due to the inability to foster meaningful social connection and co-presence. In-person
programs can foster meaningful social connections and co-presence. Unfortunately, these solutions are only
accessible to those with the time, money, and geography to have access, and furthermore, these solutions
cannot scale effectively. To address the significant unmet need for a multi-modal intervention to delay the onset
of and halt the progression of AD and ADRD, RalphVR is developing VRSingTogether, a scalable digital
therapeutic that fosters social engagement, mental activity, and physical activity with music, singing, and
light physical activity through rhythmic elements in a collaborative and shared virtual space. VRSingTogether is
a networked (multi-user) VR application to be offered on low-cost commercially available VR headsets. RalphVR
is applying for this NIA Phase I SBIR to achieve three Specific Aims. Aim 1: Employ a focus group of experts to
generate critical insights for RalphVR to develop a design document. Aim 2: Develop the VRSingTogether
prototype. Aim 3: Investigate the feasibility and usability of VRSingTogether in patients with age-related MCI
(≥65 years of age) and the individuals who care for them (≥18 years of age). Three long-term objectives must be
met to bring VRTogether to market: 1) determine the feasibility of VRSingTogether to mitigate the effects of AD
and ADRD, 2) determine VRSingTogether’s efficacy to promote light physical, cognitive, and social activity, and
3) determine the efficacy of VRSingTogether as an intervention to slow or halt the onset of AD and ADRD.
Successfully completing the long-term goals and aims will result in a clinically validated scalable and low-cost
intervention to mitigate the effects of AD and ADRD.

Public health relevance
Project Narrative A multi-modal digital therapeutic that fosters social engagement, mental activity, and light physical activity through singing, music therapy, and gaming, to provide a low-cost and scalable strategy to delay or halt the onset of Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias (ADRD). Current digital health applications are unable to foster meaningful social connection and co-presence, severely limiting their efficacy relative to in-person strategies, while in-person strategies are costly and hard to scale. This project intends to develop a cheaper, more effective, and more scalable digital therapeutic, impacting research in areas of digital health, digital therapeutics, virtual reality, virtual co-presence, and psychosocial interventions for AD and ADRD.